Enrichment Program

Project Summary/Abstract - Enrichment Program
The goals of the Michigan Center for Diabetes Translational Research (MCDTR) Enrichment Program are to:
• Advance research along the spectrum of diabetes T2-T4 translational research to prevent diabetes and
enhance health and wellbeing of people with diabetes, with a specific emphasis on novel approaches to
improve health equity in diabetes through education and training programs.
• Promote scientific exchange among investigators, cross-sectoral collaborators, trainees, and investigators
from other fields, locally, regionally, nationally, and internationally to promote new scientific collaborations,
directions, and approaches.
• Develop and support early stage investigators to conduct research focused on improving diabetes
prevention and treatment in health system and community settings through multi-modal, transdisciplinary
research methods.
To this end, the MCDTR sponsors enrichment programming including the MCDTR Annual Symposium which
brings together national and local transdisciplinary experts in diabetes translational research to present and
share research findings. The MCDTR also partners with the Institute for Healthcare Policy and Innovation
(IHPI), the Michigan Institute for Clinical and Health Research (MICHR), the Caswell Diabetes Institute,
Poverty Solutions, the Center for Research on Ethnicity, Culture, and Health, and Michigan Medicine
Community Health Services to sponsor a seminar series focused on novel health equity approaches for the
prevention and treatment of diabetes. The seminar series will provide an opportunity for investigators, cross-
sectoral collaborators, and trainees to present their research ideas, build community, and receive feedback
from MCDTR core directors. In order to develop and support early stage investigators, and ultimately build a
pipeline of diabetes translational researchers, the MCDTR will provide a dedicated seminar/workshop series
for individuals who are preparing K and R applications focused on diabetes translational efforts. The seminar
series will be focused on three intersecting fields of inquiry used to promote diabetes translational research: 1.
complex interventions at multiple levels of scale, 2. Social and behavioral determinants of health, and 3.
Dissemination and implementation science. Participants will share and receive feedback on their drafts.